ENT-based Approach to Cervical Phrenic Nerve Stimulation for the Treatment of Central Sleep Apnea

PROJECT SUMMARY
Central sleep apnea (CSA) is a disorder where patients intermittently lose the drive to breath, though they have with no
peripheral nerve disorder nor do they have any airway abnormalities, per se. CSA is thought to affect an estimated 1.0%
of people over 40 years old in the United States. If left unaddressed, poor sleep leads to daytime drowsiness, thinking
problems, and a heightened risk of errors and accidents. Furthermore, CSA is directly related to the worsening of major
cardiopulmonary diseases and is prevalent in as many as 50% of heart failure cases. As such, treating CSA can also lead
to improved cardiovascular heath, overall quality of life, and improved mortality.
Phrenic nerve stimulation is the only approved treatment for CSA; however, the current commercially available device
requires over 3-hour thoracic transvascular procedure performed by an electrophysiologist with the patient under general
anesthesia. Additionally, the referral pathway is convoluted. Thus, a due to the limited number of trained operators and
complicated surgery, many patients are not offered or eligible for this potentially life-saving treatment.
This proposal will validate a new, greatly simplified minimally invasive cervical surgical approach to phrenic nerve
stimulation. Critical to our approach is that the procedure can be performed in an outpatient setting by sleep-ENTs, who
are the logical referral for patients with CSA. Together with sleep physicians, they are already diagnosing, managing,
and treating patients with surgically implanted neuromodulation systems for obstructive sleep apnea (OSA); however
no option for CSA currently exists for them.
Our innovation exploits an anatomical region just above the clavicle where the phrenic nerve that can be accessed
comfortably by ENT surgeons by blunt resection along natural muscle boundaries with minimal risk to collateral
structures with broadly available training. It has already been demonstrated in humans that cervical phrenic nerve at this
level is fully formed and when stimulated generates physiologic tidal volumes without side-effects.
We have already completed Phase I equivalency where we developed the novel surgical approach together with two
sleep-ENT surgeon collaborators. We then designed a novel multipolar nerve stimulation cuff that minimizes the
potential for trauma to the phrenic nerve, but with features that allow it to be secured to nearby structures. Placement of
the cuff by ENT surgeons was validated in cadavers and 90-day survival preclinical studies showing ability to stimulate
phrenic nerve with the cuff using low power and near-complete healing of the implant site confirmed by histopathology.
Finally, we obtained a license to an implantable pulse generator (IPG) with specifications suitable for closed loop
phrenic nerve stimulation based on known methods developed previously and validated in clinical trials, importantly is
therapy titration based on respiration, which we plan to measure with a validated inertial measurement unit (IMU)
already on the IPG.
In Phase II of this proposal, we plan to 1) optimize the respiratory sensing capabilities to detect a variety of simulated
conditions of sleep apnea and irregular breathing patterns, 2) update the stimulation control algorithm software on the
IPG, 3) verify and validate the cuff design for chronic implantation with an FDA manufacturing partner. The safety and
durability of our system will then be demonstrated in chronic preclinical studies. The results obtained in this Phase II
will be used to support an IDE submission with the FDA.

Public health relevance
Public Health Relevance Central sleep apnea (CSA) is a disorder when you regularly stop breathing while you sleep because your brain doesn't tell your muscles to take in air. The only approved treatment for CSA is a nerve stimulation system that currently requires a long surgery and is done by a physician who does not commonly treat sleep apnea. Our proposal will validate a next generation, minimally invasive surgical approach to treat CSA that will broaden access and use of this approach.